Multidisciplinary Training in Microbial Pathogenesis

PROJECT SUMMARY / ABSTRACT
The UCLA Microbial Pathogenesis Training Grant (MPTG) is an integrated research training program in the
biochemistry, cell biology, and genetics of microbial pathogens and host-pathogen interactions. The program's
goal is to train scientists to conduct research in microbial pathogenesis using molecular, cellular, genetic,
immunological, genomic, proteomic and “post-omic” approaches. Our training faculty includes 26 preceptors with
broad ranging, related research interests in bacteriology, parasitology, virology, and immunology. Preceptors
have excellent publication, funding and training records. The program is currently in its 35th year of funding.
MPTG is small, with five predoctoral and two postdoctoral funded positions; yet it plays a vital role in educating
PhD students and postdoctoral fellows, not limited to trainees, in the field of microbial pathogenesis. Most
predoctoral trainees are recruited through the Graduate Program in Biosciences (GPB) which provides an
excellent pool of 406 predoctoral students on average yearly. Approximately 25% of GPB PhD students are
interested in microbiology, immunology and host:pathogen interactions. Our faculty are also highly successful in
attracting qualified postdoctoral fellows, having a mean of 15 postdoctoral fellows eligible for support per year.
Trainees are selected for funding on a competitive basis, after a thorough review of their accomplishments.
Progress is reviewed throughout the year and appointments are competitively renewed yearly with a maximum
of three years of support for predoctoral trainees and two years for postdoctoral trainees. The program requires
the completion of coursework focused on microbial pathogenesis, annual presentations of trainee research in
symposia attended by all trainees and preceptors, and participation in a Microbial Pathogenesis seminar series
composed of external, preeminent scientists in the field. Trainees also participate in a journal club focused on
host:pathogen interactions and newly emerging infectious agents. These journal clubs are jointly facilitated by
training preceptors and trainees and serve to broaden trainee exposure to the multidisciplinary field of microbial
pathogenesis and cutting-edge technologies. New components of the training program in this funding period
include community outreach and underrepresented student lab mentoring requirements. Participation in courses
devoted to ethics and accountability in biomedical research, rigor & reproducibility, scientific writing and
mentoring courses are also required. Development of career objectives guided by “My Individual Development
Plan (IDP)” is also required. Postdoctoral trainees also participate in the PhD Career Training Series and
research-related career focused workshops. Career counseling by the program director and training grant
advisory committee is emphasized. Annual research presentations at national meetings and UCLA retreats are
expected. The focal point of our training program is excellence in research. Several mechanisms are in place to
monitor and facilitate trainee progress in research and career development. Our past training efforts have been
highly successful and continued success is anticipated following the plan described in this proposal.

Public health relevance
PROJECT NARRATIVE The UCLA Microbial Pathogenesis Training Program provides essential support that unites students, postdoctoral fellows and faculty conducting research on pathogens that cause immense morbidity and mortality, and the host immune responses to these agents. Trainees are broadly educated in an array of biochemical and cellular mechanisms critical for establishing and maintaining microbial infections, as well as approaches used to combat diseases. Developing and achieving research career objectives are also integral components of our training program.